Lupus Omics Cutaneous Kidney Investigative Team (LOCKIT)

As the pace of discovery in the biology, genetics, and environmental regulation of SLE accelerates, the speed
and efficiency of translational application assumes even greater importance. There is now unprecedented
opportunity to harness technological advances to de-and reconstruct the enormity of phenotypic and
immunologic heterogeneity in this prototypic autoimmune disease. Building on our clinical infrastructure and
technical protocols that yielded high-quality tissue, urine and peripheral cells for transcriptomic and proteomic
analyses in AMP1, an expanded team of multi-disciplinary investigators together form the Lupus Omics
Cutaneous Kidney Investigation Team (LOCKIT) in response to the FOA: Accelerating Medicine Partnership
Autoimmune and Immune-Mediated Diseases (AMP AIM) Program. Collective team discussions aligned the
most significant scientific opportunities with clinical needs to focus on the kidney and skin, each with its own
challenging heterogeneity. Understanding the molecular underpins of both very early kidney disease (with
comparisons to data on established/relapsed disease generated in AMP1) and treatment inadequacies overall
were considered high priority goals in the field, as were differentiating acute from chronic cutaneous disease and
monitoring differences in treatment responses in these skin disease subsets. Availability of tissues to other teams
will be complementary as biology is compared across diseases. Replicating successes of AMP1, LOCKIT will
be led by the co-chairs of AMP1 SLE Clinical Working Group, Jill Buyon, NYU School of Medicine and Michelle
Petri, Johns Hopkins University. They are joined by nephrologist Brad Rovin, Ohio State University, and
dermatologist Victoria Werth, University of Pennsylvania, each recognized for translational contributions to SLE.
To accomplish our directives and assure sufficient representation of underrepresented minorities among
patients, included are three high-recruiting AMP1 sites led by Anna Broder, Albert Einstein College of Medicine;
Maria Dall’Era, University of California San Francisco; and Jennifer Anolik, University of Rochester (co-chair of
AMP1 and PI of RA site, adding B cell expertise). Two new sites, led by Karen Costenbader, Brigham and
Women’s Hospital, and Ben Chong, University of Texas, Southwestern, bring expertise in patient outcomes and
cutaneous lupus, respectively. All collaborate and publish together with cohorts collectively totaling 5,541
patients consenting to registries, and archived specimens including 98,980 longitudinal blood derivatives, and
3,311 kidney and 715 skin biopsies. To uniformly anchor discoveries, as in AMP1, Jeff Hodgin, University of
Michigan will lead a digital imaging repository. LOCKIT is poised to apply state-of-the-art technologies and next
generation analytics provided by scientific partnership with AMP AIM Cores to interrogate tissues and biologic
fluids from informative populations. Although focusing on the kidney and skin, our cohorts include all SLE
manifestations, providing agility to address other organs as AMP AIM evolves. LOCKIT commits to harmonize
and optimize all aspects of the data pipeline, from collection to analysis, interpretation and dissemination.

Public health relevance
NARRATIVE Serving as one of four disease teams of the Accelerating Medicines Partnership and Autoimmune Mediated Diseases (AMP-AIM) consortium, the Lupus Omics Cutaneous Kidney Investigative Team (LOCKIT) will enroll and follow an estimated 400 patients with Systemic Lupus Erythematosus (SLE) from nine centers across the country. The initial focus of inquiry will be on the kidney and skin given the high prevalence, severity, and remarkable heterogeneity with which SLE manifests in these organs, and the considerable but poorly understood influences of race, ethnicity, and socioeconomic status on disease phenotypes. With a high priority on identifying early kidney involvement and understanding what drives the range of skin rashes from acute to chronic, state-of the art and next generation analytics will be applied to interrogate tissues, blood, and urine from our informative populations, with the ultimate goal to identify novel targets for intervention.